Enhancing multidisciplinary research at Mayo with a state-of-the-art 7T preclinical MRI

PROJECT SUMMARY/ABSTRACT
The Mayo Clinic in Rochester, MN seeks funding to acquire the Bruker BioSpec 70/20 magnetic resonance
(MR) imaging scanner, featuring a 7.0 Tesla magnet and a 20 cm horizontal bore. This instrument will
significantly advance our research capabilities by addressing existing gaps in preclinical imaging. The chosen
bore size and system configuration are deliberately selected to accommodate a wide range of small animal
models, from zebrafish, mice (capable of imaging multiple mice simultaneously) to adult rats, essential for
ongoing studies in neuroscience, cancer research, cardiovascular diseases, and beyond. This flexibility is
crucial for implementing advanced imaging applications such as MR elastography, which requires extra space
for actuators within the bore in contact with the subject to generate mechanical waves in soft tissues,
enhancing our research capabilities in mechanical tissue properties from head to toe.
The horizontal configuration of the BioSpec 70/20 is strategically justified to overcome physiological and
technical limitations experienced with obsolete vertical NMR systems, such as organ shift due to gravity, which
affects the consistency of quantitative imaging results. Horizontal positioning also facilitates easier access to
the subject during scans, crucial for dynamic contrast-enhanced MRI and functional MRI, where precise and
repeated interventions are required.
Equipped with a high-performance gradient system and a 16-channel receiver, the BioSpec 70/20 will enable
sophisticated quantitative imaging techniques essential for cutting-edge research. These include high-
resolution diffusion tensor imaging for neurology studies, arterial spin labeling for assessing cerebral and tissue
blood flow, and advanced cardiac imaging to capture the fast dynamics of small animal hearts. The system's
superior gradients and slew rates are critical for applications requiring high signal-to-noise ratios and rapid
acquisition times, such as diffusion-based cytometry and functional imaging of neuronal activity.
The broad, long-term objectives of acquiring this system include enhancing our understanding of disease
mechanisms and therapeutic responses at a microstructural level across multiple research programs. This
system will support significant advances in liver disease research by enabling high-resolution imaging to
evaluate fibrosis and inflammation, brain disease research through precise imaging of neurodegeneration, and
nephrology and cardiovascular research by allowing detailed assessments of cardiac function, renal function
and vascular morphology. In conclusion, the acquisition of the BioSpec 70/20 MRI system will transform the
Mayo Clinic’s research landscape, bridging the gap between preclinical findings and clinical applications, and
maintaining our leadership in biomedical research. This investment will not only advance our current projects
but also pave the way for new discoveries and innovations in medical science.

Public health relevance
PROJECT NARRATIVE The state-of-the-art small animal MRI system will help researchers at Mayo Clinic better understand diseases like cancer, liver, kidney, heart, and brain diseases, leading to better treatments and cures. It will improve diagnostic techniques by providing high-resolution images of disease models, directly benefiting patient care. It will also accelerate the development of new therapies, improving health outcomes for the public.